HBV cccDNA and integrated DNA in HIV coinfection and HBV monoinfection

Project summary/ Abstract:
Chronic hepatitis B (CHB) remains a substantial public health burden despite the availability of effective vaccines
and approved therapies. Functional cure with HBsAg clearance is the current HBV treatment endpoint. Although
prolonged therapy with nucleos(t)ide analogs can suppress HBV DNA replication, the rate of functional cure
remains low. With functional cure, it is expected that the intrahepatic cccDNA would be in a transcriptional
inactive state regardless the status of the integrated HBV DNA (iDNA). We and others provided evidence that
the iDNA produces a major source of HBsAg especially in HBeAg-negative CHB. The current serum assay
cannot distinguish HBsAg generated from intrahepatic cccDNA versus iDNA. In this proposal, we focus to 1)
evaluate both the concentrations and the transcriptional activities of cccDNA and iDNA in CHB with and without
HIV; 2) assess the roles of epigenetic mechanisms in cccDNA and iDNA transcription in treatment response;
3) compare the intrahepatic and plasma iDNA levels, and to correlate iDNA levels with HBsAg titers and
treatment outcomes; 4) evaluate second generation serum HBV pgRNA and novel HBV core Ag (HBcAg)
biomarkers as surrogate markers for cccDNA; 5) apply the clinical, serological and virological parameters to
generate predictors of treatment-induced transcriptionally inactive cccDNA and HBsAg loss. This is a unique
translational research study that utilize well-characterized liver and blood samples as well as advanced molecular
technologies and methods to understand the virological mechanisms of HBV persistence, inactivity, and
clearance. The success of our study will have significant impacts in the development of novel therapies leading
to a complete HBV cure.

Public health relevance
Project Narrative Hepatitis B virus infection affects more than 296 million people globally and is a major cause of cirrhosis and hepatocellular carcinoma (HCC); these complications are particularly high among patients with HBV/HIV coinfection. Complete HBV cure with the elimination of cccDNA and integrated HBV DNA (iDNA) can definitively arrest the disease progression and HCC risk, but these are unattainable with current therapy. We aim to understand the molecular details of cccDNA and iDNA transcriptional activities in both HBV/HIV coinfection and HBV mono-infection that can facilitate the development of novel HBV therapies for a complete HBV cure.